Cascade Amplification Biosensor Technology for Detecting MicroRNA Biomarkers of Alzheimer Disease

The goal of this project is to develop a novel molecular diagnostic technology, called “Cascade Amplification by
Recycling Trigger Probe” (CARTP), for rapid, multiplex, and ultra-sensitive detection of circulating microRNA
(miRNA) biomarkers in clinical plasma samples for early detection of Alzheimer’s disease (AD). Circulating
miRNAs have been identified as promising non- or minimally-invasive diagnostic biomarkers in many diseases,
including neurodegenerative diseases such as AD. However, because of technical difficulties arising from
analytical aspects in the lab, the detection of these small molecules has not been adopted into clinical practice.
Common miRNA detection methods, including qRT-PCR, northern blot, microarray, and next-generation
sequencing (NGS), are often elaborate, time-consuming, and expensive. There is a need to develop alternative
molecular assay strategies that may offer more advantages over conventional methods and have the potential
to enhance research in the areas of early detection, screening, and clinical diagnosis. Our laboratory has
pioneered the development of a unique homogeneous surface-enhanced Raman scattering (SERS)-based
inverse Molecular Sentinel (iMS) nanobiosensor for multiplex detection of miRNAs. The proposed CARTP
technique is designed to improve the detection sensitivity of the iMS by amplifying the SERS signal upon
detection of targets. Although miRNAs related to AD will be used as the model system, the proposed project will
also lead to the development of a generally applicable diagnostic technology for other types of diseases.
The following specific aims promote the development of the CARTP technology: (1) Develop the new CARTP
molecular analysis method for multiplex detection of miRNA biomarkers; and (2) Technical evaluation of the
CARTP for AD diagnosis using clinical samples. In the technique development phase (Aim 1), we will develop
and optimize iMS+CARTP nanoprobes for multiplex detection of 3 miRNAs selected from our NGS analysis. The
analytical features of merit (specificity, sensitivity, multiplex capability) of the new CARTP technology will be
investigated in detail using synthetic targets. In the technical validation phase (Aim 2), the assays will be
performed on RNA extracted from clinical plasma samples; results will be compared with NGS data. The
performance criteria will include specificity, sensitivity, and multiplex capability provided by the CARTP assay.
We will define and test performance measures that could substantiate the expectations of the potential
transformative impact of the CARTP technology on AD diagnostics. The proposed technology will lead to a novel
“sample-to-answer” analysis approach that is simple and robust to allow successful routine use by minimally
trained clinical personnel. The new CARTP technology is capable of enhancing research and translation in the
areas of early detection and screening of various diseases beyond AD; it is ultimately better suited for the clinic
or point-of-care. The proposed molecular analysis technology represents a significant innovation with
transformative potential in biomedical research, diagnostics, and screening.

Public health relevance
Circulating microRNAs have been identified as promising diagnostic biomarkers in many diseases, including neurodegenerative diseases such as Alzheimer’s disease (AD). We propose to develop the Cascade Amplification by Recycling Trigger Probe (CARTP) technique to significantly enhance the detection sensitivity of microRNA biomarkers in clinical plasma samples for AD diagnostics. Although microRNAs related to AD will be used as the model system, the proposed technique will also lead to the development of a generally applicable diagnostic technology for other types of diseases.